Diversity Supplement - Effects of microgravity on the structure and function of proximal and distal tubule MPS

ABSTRACT The goal of the parent grant is to evaluate the effects of microgravity on kidney tubule structure and function. These discoveries will improve public health by informing novel strategies for the design and development of better treatments for proteinuric kidney disease, osteoporosis, and kidney stones in the general public. Kidney dysfunction can precipitate serious medical conditions including proteinuria, osteoporosis, and formation of kidney stones. These conditions occur more frequently, and progress faster, in crewmembers stationed on the International Space Station. Current static models of the proximal and distal tubules are unable to recapitulate cellular functions including protein reabsorption via megalin, vitamin D metabolic bioactivation, and micro-crystal mediated injury response. We have developed a microphysiologic model of the proximal tubule using primary proximal tubule epithelial cells (PTECs) that has successfully demonstrated physiologic cellular structure/polarization, transport of glucose and drug substrates, bioactivation of inactive 25- hydroxy vitamin D to 1?,25-dihydroxyvitamin D (which promotes beneficial bone remodeling), and physiologic injury response to toxic exposure. We will expand this technology to develop a distal tubule epithelial cell model (DTEC) which will be used to explore the pathophysiologic response to oxalate microcrystals. Studying the proximal and distal tubules in the microgravity environment of the International Space Station presents the unique opportunity to observe accelerated disease processes (proteinuria, osteoporosis, kidney stones), which will facilitate the discovery of factors that contribute to the development and progression of kidney diseases that cannot be observed on a conventional time scale. Therefore, the aims of this project are: to determine the effects of microgravity on the polarized structural aspects (eg., ion and solute transporters) of the kidney proximal and distal tubule epithelium in a 3D microphysiological system, to determine if Vitamin D bioactivation/homeostasis within the kidney proximal tubule is compromised in response to extended exposure to microgravity, and to create a disease-state models of proximal tubule proteinuria and distal tubule kidney stone formation to evaluate the harmful or adaptive modulating effects of microgravity. A better understanding of the factors and pathways that underlie proper cellular structure and the development and progression of kidney diseases will uncover novel therapeutic targets that can be used in the development of pharmacologic agents that can improve the health of Space Station crewmembers as well as the health of the general public by preventing or reversing proteinuria, osteoporosis, and kidney stones. We have requested support under the Diversity Supplement mechanism for Mr. Kendan Jones-Isaac, a student in the Pharmaceutics PhD program at the University of Washington. Mr. Jones-Isaac has been an active and engaged student, with a keen interest in the development of new tools and devices to accelerate pharmaceutical science research. He has shown exceptional aptitude at mentoring undergraduates and visiting scientists. His mentoring team is composed of Drs. Edward J. Kelly (primary mentor), Catherine K Yeung (co-mentor), and Jonathan Himmelfarb (senior mentor), who are all fully committed to providing Mr. Jones-Issac with the support and mentoring necessary for a competitive F31 application and career as an independent investigator.

Public health relevance
PROJECT NARRATIVE The goal of the parent grant is to evaluate the effects of microgravity on kidney tubule structure and function. These discoveries will improve public health by informing novel strategies for the design and development of better treatments for proteinuric kidney disease, osteoporosis, and kidney stones in the general public. We have requested support to provide intensive mentoring and academic support for Mr. Kendan Jones-Isaac, a promising student pursing a PhD in Pharmaceutics. His mentoring team is fully committed to providing Mr. Jones-Issac with the support and mentoring required for a career as an independent investigator.